Organophosphorus pesticide bioactivation and detoxification in an invertebrate rapid screening model to study mechanisms of neurotoxicity

Objectives. Organophosphorus pesticides (OPs) have been implicated in the dramatic surge of
neurodevelopmental problems among U.S. children. Acute OP poisoning is due to inhibition of
acetylcholinesterase (AChE). Chronic exposure to environmentally relevant OP levels has been suggested to
cause developmental neurotoxicity (DNT) via alterations to cholinergic and non-cholinergic targets necessary for
nervous system development and function. We have developed a cost-effective behavioral high-throughput
screening (HTS) method for DNT studies using the asexual freshwater planarian Dugesia japonica, and shown
it to be well-suited for assessing OP neurotoxicity/DNT. We have also shown that these planarians have two
genes that are evolutionary ancestors of mammalian cholinesterases, with similar OP inhibition kinetics. These
planarians can metabolize OPs at all developmental stages and exhibit carboxylesterase (CE) and calcium-
dependent phosphoric triester hydrolase (PTEH) activity. To extrapolate planarian neurotoxicity data to human
neurotoxicity further characterization of the OP bioactivation and detoxification pathways are needed. The
overarching goal of this research is to establish planarians as a model for OP DNT. The specific objective of
this R21 Exploratory/Developmental grant is to determine the key proteins involved in OP metabolism to
contextualize planarian OP screening data, especially in the context of OP mixtures.
We will test the hypothesis that key enzymes for OP bioactivation and detoxification are conserved
between humans and planarians through 2 aims. In aim 1, we will identify and characterize OP detoxification
enzymes, CE and paraoxonase (PON). We have shown that CE and PTEH activity exists in planarians but have
not yet identified the responsible genes. Using standard molecular biology tools, we will identify gene homologs,
characterize expression profiles, and use RNA interference to verify functional significance. In aim 2, we will
identify and characterize the key cytochrome (CYP) P450s responsible for OP bioactivation and detoxification in
planarians. We have shown that OP bioactivation exists in planarians but do not know which CYPs are involved.
Because there are many putative CYPs in the D. japonica transcriptome and we don’t know a priori which CYPs
will be relevant for OP bioactivation, we will first identify relevant CYPs using a CYP inhibitor screen. We will
expose planarians to each OP +/- inhibitor for 30 minutes and quantify cholinesterase activity using an Ellman
assay. Once we have identified the CYP subfamilies involved in OP bioactivation, we will use the same strategy
as in Aim 1 to identify planarian CYP homologs and test for their functional significance.
Impact: The data generated in this project will provide a foundation for future mechanistic studies of OP DNT,
especially in the context of OP mixtures, which have been vastly understudied. By characterizing the key
machinery involved in planarian OP metabolism, we can contextualize planarian OP screening data. This
research will create unique opportunities for undergraduates in toxicology research at Swarthmore College.

Public health relevance
Chronic exposure to organophosphorus pesticides (OP), an economically important and chemically diverse class of pesticides, has been associated with developmental neurotoxicity and long-term neurological problems. Planarians have emerged as a useful alternative model to study OP neurotoxicity because they are amenable to rapid screening of OPs and OP mixtures and preliminary studies indicate that they can metabolize OPs like humans. To extrapolate planarian toxicity to human toxicity and to contextualize planarian OP screening data, further characterization of planarian OP metabolism is needed, which this project aims to achieve by identifying and characterizing key OP bioactivation and detoxification proteins.